Exploring the Immunosuppressive Role of Human Endogenous Retrovirus K in the Glioblastoma Microenvironment

PROJECT SUMMARY
Glioblastoma (GBM) is the most lethal primary brain tumor with a five-year survival rate of less than 5%. The
GBM tumor microenvironment (TME) is highly immunosuppressive, conferring resistance to immunotherapies
that have proven groundbreaking in treating other malignancies. Thus, the need to identify and target drivers
of immunosuppression in the GBM TME remains critically important. Notably, our lab recently uncovered
robust overexpression of Human Endogenous Retrovirus K (HERV-K) in GBM that is associated with poor
patient outcomes. HERVs are remnants of ancient germ-line retroviral infections that comprise ~8% of the
human genome. They are generally transcriptionally silenced, but dysregulated states like cancer can lead to
increased expression of canonical HERV genes and proteins, including env (envelope protein). This project
proposes HERV-K Env as a viable candidate to target therapeutically to improve GBM patients’ response to
immunotherapy due to robust evidence that retroviral Env proteins have immunosuppressive properties and
contain a highly conserved immunosuppressive domain (ISD). Recent results, including our preliminary data,
show that HERV-K Env inhibits proliferation of T cells, modulates cytokine secretion, and increases
expression of immune checkpoint receptors. Further, immune deconvolution of bulk RNA sequencing and
spatial transcriptomics show that high HERV-K Env expression is associated with low immune cell infiltration
in GBM and decreased survival of GBM patients. However, the mechanism by which HERV-K Env
suppresses T cell function remains elusive, and HERV-K Env’s exact role in the immunosuppressive GBM
TME remains unclear. This proposal will test the central hypothesis that HERV-K Env’s ISD mediates binding
to critical surface receptors, including CD98hc (roles in amino acid transport and integrin signaling) on T cells,
altering their downstream functions and leading to T cell dysfunction and to greater immunosuppression in the
GBM TME. Specific Aim 1 will identify critical mediators of HERV-K Env’s immunosuppressive effect on T
cells via the use of co-immunoprecipitation and mass spectrometry to identify the binding partners of Herv-K
Env on the T cell surface and to elucidate the ISD’s role; further, it will explore alterations in downstream
pathways of these receptors via methods including Western blot, qPCR, flow cytometry, and ELISA. Specific
Aim 2 will characterize HERV-K Env-mediated immunosuppression in the GBM TME by utilizing GBM-T cell
co- cultures, HERV-K Env-overexpressing orthotopic mouse models paired with single cell RNA sequencing
and multiplex flow cytometry, and spatial transcriptomics analysis of patient specimens. Altogether, this
study’s results will explain critical immunosuppressive mechanisms of a retroviral protein, HERV-K Env, in
GBM and elucidate its role in GBM’s highly immunosuppressive TME. It possesses robust translational
potential by providing a candidate to target therapeutically and by identifying key pathways in Env’s
immunosuppressive effect in GBM.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM), the most lethal primary brain tumor, resists current immunotherapies due to its highly immunosuppressive tumor microenvironment, necessitating further investigation into new therapeutic targets. Human Endogenous Retrovirus K (HERV-K), a relic of ancient retroviral infection that is integrated into human DNA, is highly expressed in GBM and produces an immunosuppressive Envelope protein (Env). This study will investigate HERV-K Env's mechanisms of immunosuppression within the GBM tumor microenvironment, uncovering intermediate pathways of retroviral Env protein-induced immunosuppression and aiming to determine HERV-K Env's potential as a therapeutic target.